University of Iowa Institutional Training Program in Oral Health Research

This competitive renewal application proposes to continue our program to provide comprehensive, integrated
training in dental and craniofacial research at the University of Iowa (UI) to a cohort of basic, clinical, and
translational researchers and dental scholars. It will provide dentists and non-dentists with a comprehensive
skillset to meet the challenges of oral health research in academia for the 21st century. Outstanding
interdisciplinary didactic training and rigorous research mentoring will emphasize ongoing review and critique.
The proposed program builds on 37 years of research training success, with several major enhancements
listed briefly below. The program addresses 7 major research training areas: 1) Craniofacial, Oral Biology,
Genetics, and Dental Development; 2) Bioengineering, Tissue Engineering, Stem Cells, Biomaterials, and
Materials; 3) Immunology, Inflammation, Microbiology, Caries, and Microbiome; 4) Oral Cancer; 5) Public
Health, Epidemiology, and Behavioral Sciences; 6) Oral Health Policy; and 7) Clinical, Translational, and Big
Data Research, reflecting the strengths of the College of Dentistry, UI health science colleges, and
collaborative institutes and centers. Trainees in the proposed program will pursue a PhD in Oral Science (or in
one of the 13 other affiliated PhD programs) or a post-doctoral fellowship. In addition, trainees now will be
able to obtain a Graduate Certificate in College Teaching, Biostatistics, or Translational and
Clinical Investigation or an MS in Dental Public Health. The T90 will support 4 non-dentist predocs and 2
dentists for the PhD (3 years each) and 1 non-dentist postdoc (2 years). The R90 component reflects the
importance international dentists have in U.S. oral health research programs and will support 2 dentists for
the PhD (3 years each). A group of 28 experienced program faculty from a variety of disciplines is available to
mentor trainees. The success of our program over the past 4+ years is seen in 5 trainees receiving F- or Kawards since 2019 and trainees’ successful career placement. To build on this success, we propose several improvements/new major components of this Institutional Training Program. The successful Grant-Writing
Workshop Series has been updated and enhanced. Additionally, we propose several new programs, including
ones in Research Rigor, Research Leadership Development, and Interdisciplinary Faculty Mentoring. Training
will be supervised by the experienced Director and Associate Director and implemented in concert with a
Faculty Leadership Team. Future participant selection will be made solely on the basis of merit. Several
committees will support the program: internal and external advisory committees, and other componentspecific committees. In summary, the program brings together productive, well-funded mentors with pre- and
post-doctoral trainees in an environment with a strong institutional commitment, outstanding interdisciplinary
research training in relevant disciplines, and excellent educational and research facilities. The outcome will be
a cadre of oral health researchers ready to function at the cutting edge of their disciplines.

Public health relevance
Project Narrative The proposed continuation of our institutional oral health research training program is designed to provide training opportunities at the PhD and post-doctoral levels for both dentist and non-dentist scientists, including training in translational and clinical research, research rigor and reproducibility, and the responsible conduct of research. This program is designed to allow trainees to develop the complex skills necessary to undertake independent and collaborative research, and thus to become oral health research scholars capable of meeting future opportunities and challenges in dental education and oral health research.